Endotheliopathy and liver injury in COVID-19

COVID-19, caused by SARS-CoV-2 infection, is a multisystem disease. SARS-CoV-2 infection in airway cells
and other tissues results in excessive production of proinflammatory cytokines, which can lead to pulmonary
failure. The lung damage is caused in part by thrombotic complications from endotheliopathy, a form of
endothelial dysfunction characterized by a proinflammatory and procoagulant state. This is a major cause of
morbidity and mortality in patients with COVID-19. Clinical liver injury is often observed in COVID-19 and is
associated with a worse prognosis than in patients without liver injury, but the pathophysiology remains
unknown. The goal of our proposal is to determine the mechanism of liver injury in COVID-19.
The presence of thrombosis was reported in the livers of COVID-19 patients. We found that liver injury
(ALT greater than three times the upper limit of normal) is associated with an increase in procoagulant factors
in the blood (n=3,830) and in liver tissue (n=48) from COVID-19 patients. Given that endotheliopathy activates
the coagulation cascade and leads to platelet adhesion to the endothelium, which promotes thrombosis, we
hypothesize that an excessive immune response to SARS-CoV-2 infection leads to endotheliopathy in the
liver microcirculation, causing liver injury.
IL-6 is a proinflammatory cytokine that is highly elevated in the blood of COVID-19 patients. We found
that IL-6 levels were significantly higher in COVID-19 patients with liver injury than those without. IL-6 levels
also positively correlated with plasma levels of von Willebrand factor (vWF), an indicator of endotheliopathy.
IL-6 can initiate intracellular signaling both through a membrane-bound IL-6 receptor (IL-6R) (classical IL-6
signaling) as well as by binding to soluble IL-6R (sIL-6R). The latter is known as IL-6 trans-signaling and
allows IL-6 signaling into cells not expressing IL-6R on the cell surface, such as liver sinusoidal endothelial
cells (LSECs), as long as they express gp130. We thus hypothesize that IL-6 trans-signaling causes LSEC
endotheliopathy (a proinflammatory and procoagulant state) and liver injury observed in COVID-19 patients,
and that blocking this pathway will ameliorate endotheliopathy. Two aims are proposed.
Aim 1 Determine the mechanism of LSEC endotheliopathy that leads to liver injury in COVID-19.
Aim 2 Determine potential therapeutic targets for LSEC endotheliopathy in COVID-19.
New therapies for COVID-19 will be needed for a long time to come. Here we will examine in a
mechanistic manner a new therapeutic strategy for COVID-19 and its endotheliopathy. Because IL-6 signaling
is largely unexplored in ECs, findings from this study will advance our understanding of not only the
mechanism of thrombosis in the liver microcirculation, but also EC biology in general. Further, our model of IL-
6 driven liver injury is likely to be highly broadly relevant to SARS-CoV-2 endothelial injury and could also
provide attractive therapeutic targets.

Public health relevance
NARRATIVE COVID-19 due to SARS-CoV-2 infection causes excessive production of proinflammatory cytokines and a pulmonary failure. Clinical liver injury is frequently observed in COVID-19 patients and is related to poorer outcomes. The goal of our proposal is to determine the mechanism of liver injury in COVID-19 arising due to endothelial dysfunction called endotheliopathy in the liver.